Neurobiological Underpinnings of Placebo Response in Depression

DESCRIPTION (provided by applicant): Major depressive disorder (MDD) is a serious, debilitating illness that affects 16.6% of the US population in their lifetime. One of the most critical issues in developing new treatments is that in double-blind clinical trials the administration of placebo in MDD can often mimic the effects of FDA-approved antidepressants and lead to a significant improvement in approximately 35% of patients. At present the neurobiological mechanisms underlying placebo responses in MDD are unknown. We hypothesize that mesolimbic dopaminergic pathways implicated in reward anticipation, reinforcement learning, and expectation play a critical role in mediating placebo responses in MDD. In this research we will use integrated PET/fMRI imaging techniques, to compare simultaneously [11C]raclopride displacement (an indirect measure of endogenous dopamine release) and BOLD signals within the mesolimbic pathways in patients with MDD who are responders versus non-responders to placebo. The proposed research is profoundly innovative with respect to trial design, technology, and its multi-level integration, probing psychological an neurobiological constructs assumed to be crucially implicated in placebo response. A better understanding of the neurobiological basis of placebo effect has enormous potential for harnessing the healing capacity of placebo, developing new generations of clinical trials yielding better differentiation between novel antidepressants and placebo, and ultimately leading to new treatments for MDD.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research combines an innovative trial design, manipulation of expectations, and neuroimaging techniques to investigate the contribution of dopaminergic mesolimbic pathways to placebo responses in major depressive disorder (MDD). This interdisciplinary, multi-modal approach is designed to illuminate the neurobiological basis of placebo response in MDD, with the expectation that this will lead to (1) identification of biomarkers and biosignatures of placebo responders, (2) new opportunities to manipulate the system from a treatment standpoint, possibly decreasing or eliminating a major confounder in clinical trials (excluding from randomization those most likely to respond), and (3) refining treatments with approaches that decrease (in clinical trials) or increase (in clinical practice) th placebo response.